Towards a structural understanding of transcriptional regulation by ZMYM2-KDM1A-CoREST

PROJECT SUMMARY / ABSTRACT
Tight regulation of transcription is critical for human health. ZMYM2 associates with the KDM1A-CoREST
complex on chromatin and acts as a localization signal for complex partners mediating transcriptional repression.
Detailed understanding of how transcription factors, like ZMYM2, recruit chromatin modifying complexes to
specific promoters and achieve transcriptional regulation is lacking. Several pediatric cancers emerge due to
disruption in chromatin and epigenetic states. Gene regulation has long been considered "undruggable".
Mechanistic studies of transcriptional regulation will build the foundation for the development of new therapeutic
approaches to modulate chromatin and gene regulatory machineries. KDMA1 is a promising target for epigenetic
regulation, several KDM1A inhibitors are under development for acute myeloid leukemia, but further investigation
is required to enhance our understanding of the underlying mechanism of therapeutics modifying gene
expression on a molecular level.
As a postdoc in the Fischer and Armstrong laboratory, I aim to strengthen my ability to innovate and
advance experimental therapeutics in the field of pediatric hematologic malignancies and more importantly
supplement my previous skillset in cancer biology with integrative structural biology and mechanism-based
research. I am developing expertise in biochemical and structural biology so that I can help drive the
understanding of aberrant transcription in pediatric cancer and lay the groundwork for new therapeutic
development.
I propose a multifaceted approach combining proteomics, biochemical characterization, functional
assays, and cryo-electron microscopy studies of the ZMYM2-KDM1A-CoREST complex to understand the
regulation of gene expression by ZMYM2-KDM1A-CoREST and more generally how transcription is regulated
on a molecular level.
I propose to determine a high-resolution three-dimensional structure of the ZMYM2-KDM1A-CoREST
complex, providing insights into the molecular mechanisms by which transcriptional regulation is achieved (aim
1). I will then characterize the function of transcription factors and members of distinct chromatin modifying
complexes in vitro. I will study how transcription factors, like ZMYM2 directly mediate the demethylation or
deacetylation of histones by its interacting proteins KDM1A or HDACs, respectively (aim 2). Finally, I will
characterize the role of ZMYM2-KDM1A-CoREST at specific promotors in various biological settings in the living
cell (aim 3).
Understanding how ZMYM2-KDM1A-CoREST mediates transcriptional regulation can inform general
approaches to modulate aberrant transcription. Overall, this study aims to provide a deep understanding of the
molecular mechanisms underlying transcriptional regulation in a cell type and fate specific manner. The results
of this study will inform the development of new therapeutics targeting aberrant transcription in pediatric hard-to-
treat cancers.

Public health relevance
PROJECT NARRATIVE Genome organization is essential for gene regulation, which controls cell fate commitment and differentiation. I utilize integrative structural biology, combining proteomics, biophysics, structural biology, biochemistry, and cell biology to elucidate how transcription factors act as localization signals for large chromatin modifying complexes and how transcription is regulated in various cell types. These studies will enhance the molecular understanding of the regulation of gene expression and inform the development of novel chromatin modifying therapeutics for hard-to-treat pediatric cancers.